ULTRASTRUCTURE AND CYTOCHEMISTRY OF SECRETORY CELLS

Basic mechanisms of the secretory process are studied in cells of the rat pancrease, salivary and lacrimal glands. Techniquies utilized include light and electron microscopy, enzyme- and immunocytochemistry, radioautography, and biochemistry. Major areas of investigation are: (1) the structure and function of the Golgi apparatus and GERL; (2) experimental pathology and lysosome function in salivary glands; (3) structure and permeability properties of junctional complexes in the rat parotid gland; (4) the role of salivary duct cells in protein reabsorption; (5) structure and cytochemistry of the salivary gland of the rat soft palate; and (6) parotid Beta-adrenergic receptor localization using labeled antagonists.